The role of mitochondrial dysfunction in ARDS after AKI

Acute kidney injury (AKI) occurs in 30% of critically ill veterans, and the 6-year mortality rate is greater
than 50%1,22. Interestingly, the leading causes of death in AKI are non-renal complications, and respiratory
failure is the most serious non-renal complication of AKI with a worse prognosis than all other remote organ
failures4. It is now recognized that there are mechanisms of respiratory failure in AKI beyond volume overload,
such as the development of the acute respiratory distress syndrome (ARDS)2-3. Investigating the mechanisms of
ARDS due to AKI may lead to the development of novel strategies to improve the mortality of AKI and ARDS.
Regarding mechanistic considerations, the kidney is a highly metabolic organ in the body with an
exceptionally high mitochondrial content, therefore mitochondrial dysfunction is a key element in various forms
of AKI5,7. Mitochondrial dysfunction as seen in AKI leads to fragmented mitochondria which function as damage
associated molecular patterns (DAMPs) that propagate systemic inflammation and injury12,13. Mitochondrial
DNA (mtDNA) is the most well-described mtDAMP, and has been shown to promote innate immunity and
systemic inflammation via activation of toll-like receptor 9 (TLR9)18. MtDNA is also known to cause lung injury
when administered intravenously to healthy animals18. I hypothesize that mitochondrial dysfunction is a
mechanism of ARDS due to AKI. Specifically, 1) Mitochondrial dysfunction in AKI leads to mtDNA
fragmentation and release into circulation. 2) Circulating mtDNA released from the kidney leads to lung injury
via TLR9 activation on pulmonary cells and neutrophils. AKI patients are also twice as likely to require
mechanical ventilation compared to patients without AKI6, and mtDNA damage is a known mechanism of
ventilator induced lung injury (VILI)20. I further hypothesize that AKI increases susceptibility to VILI, and VILI
after AKI worsens lung and kidney injury by potentiating mitochondrial dysfunction in both organs.
I will utilize the ischemia-reperfusion (IR) model of AKI to test these hypotheses. Mitochondrial
function, dynamics, autophagy, and cell death will be evaluated in the lung and kidney after IR-AKI. MtDNA
levels will be evaluated in urine, plasma, and bronchoalveolar lavage fluid (BALF). Detailed, mechanistic studies
of mtDNA on pulmonary epithelial and endothelial cells, alveolar macrophages, and neutrophils will be
performed in vitro. Intravenous and intratracheal mtDNA administration will be evaluated in C57BL/6 and
TLR9 knockout mice in vivo. Western blot, ELISA, quantitative PCR, transmission electron microscopy, FACS
analysis, lung mechanics assessments via a flexiVent® rodent ventilator, XF96 Seahorse® extracellular flux
analyzer, and FITC-inulin kinetics will be used to assess lung and kidney injury, mitochondrial function, and
mtDNA release after IR-AKI. I will also investigate response to mechanical ventilation in mice with and without
IR-AKI to evaluate the potential role of VILI on lung and kidney injury and mitochondrial function after AKI.
Finally, I will attempt to mitigate lung-kidney injury using a mtDNA repair enzyme.
My immediate goal is to investigate mitochondrial dysfunction as a mechanism of ARDS due to AKI as I
believe that these studies will lead to novel therapies that will benefit veterans suffering with critical illness. My
long term career goal is to develop the skills needed to become an independent physician-scientist at the VA
dedicated to lung-kidney interactions. I have a strong clinical background in caring for veterans as a pulmonary-
intensivist, and 2 years of dedicated research training. During the past 2 years I have produced and published
novel data supporting my hypotheses, and garnered support from a world-class, multidisciplinary, mentoring
team at the VA San Diego that will train me in basic, translational, and clinical research. The research training
proposed in this application combined with didactic training in AKI, ARDS, and mitochondrial biology will
provide me with the tools necessary to develop my independence as a physician-scientist at the VA San Diego.

Public health relevance
Acute kidney injury (AKI) in the critically ill veteran population has been shown to be highly prevalent with a high independent mortality1,23. Additionally, the incidence of AKI is rising and poses a major burden on the VA healthcare system24. Despite advances in management of the renal complications of AKI, the mortality of AKI in the ICU remains unacceptably high at over 50%1. AKI has been shown to increase the risk of developing the acute respiratory distress syndrome (ARDS), and ARDS is a leading cause of death due to AKI4. The mortality of AKI leading to ARDS is 60-80%6, yet lack of understanding of the mechanisms involved has precluded the development of novel therapies to prevent ARDS due to AKI. The research proposed here is designed to identify mitochondrial dysfunction as a mechanism of AKI-ARDS crosstalk. Successful completion of the experiments proposed will greatly enhance our understanding of lung-kidney interactions, and lead toward the development of targeted therapies to increase the quality of care provided to critically ill veterans.